Precise image guidance for liver cancer stereotactic body radiotherapy using element-resolved motion-compensated cone beam CT

Project Summary
Liver cancers, both primary and metastatic, are increasing in incidence and are associated with significant
mortality. Stereotactic Body Radiotherapy (SBRT) has been established as an effective, safe, and feasible first-
line option in the local control of unresectable hepatic malignancies. Nonetheless, a large margin (typically
~1cm) has to be used in current liver SBRT to accommodate tumor positioning uncertainty under cone-beam
CT (CBCT) image guidance. Because of respiratory motion and vanishing tumor contrast, the tumor target
cannot be visualized in CBCT. Inferior tumor positioning approach based on anatomical or implanted
surrogates are clinical standard, leading to substantial tumor position uncertainty and a typical margin size of
~1cm. Consequently, high dose to a large volume of normal tissue is delivered, causing a toxicity concern,
especially in patients with liver dysfunction caused by cancer and/or treatments is more substantial. In addition,
normal tissue toxicity limits further dose escalation to improve clinical benefits. This issue is expected to
become more severe, when extending SBRT to a wider patient population, e.g. those with a large tumor size.
Several emerging imaging approaches have showed potential to improve image guidance accuracy but also
encountered challenges. To date, there is no approach that can provide accurate, reliable, and clinically
translatable image guidance for liver SBRT. Recently, our group has made a breakthrough towards
reconstructing elemental composition image using a standard CBCT platform. Employing a kVp-switching
technique, a novel image reconstruction method with spatial and spectral image regularization, as well as a
sparse-dictionary based element decomposition method, we achieved ~3% accuracy in elemental composition
as tested in phantom studies. We have also accumulated extensive experience in reconstructing high-quality
CBCT images under respiratory motion. Armed with these successes, the overall goal of this study is to
develop a novel element-resolved and motion-compensated (ERMC-) CBCT to image iodine contrast agent
using only 20% contrast injection in a standard treatment planning CT scan for precise (uncertainty <2mm)
image guidance in liver SBRT. We will pursue three specific aims (SAs): SA1. Develop the overall ERMC-
CBCT system. SA2. Optimize scan parameters via phantom studies. SA3. Perform studies in 10 patient cases
to test safety, feasibility, and tumor positioning accuracy of ERMC-CBCT based image guidance. The
innovation of this project is a novel ERMC-CBCT system and its application for a clinically significant problem
of tumor localization in liver SBRT. Besides the significance of substantially improved localization accuracy and
therefore clinical potential of normal tissue sparing and dose escalation, our project also holds the significance
of utilizing CBCT to its maximal potential for many other advanced image guidance tasks and quantitative
applications. The ERMC-CBCT system is developed on a conventional CBCT platform, the most widely
available image-guidance platform in radiotherapy, ensuring its translatability.

Public health relevance
Project Narrative Stereotactic body radiotherapy (SBRT) has been established as an effective, safe, and feasible first-line option in the local control of unresectable hepatic malignancies. A large margin of ~1cm has to be used in current liver SBRT to accommodate tumor positioning uncertainty under cone-beam CT (CBCT) image guidance. This study will develop a novel element resolved motion compensated CBCT system to image low-dose iodine contrast agent. Successful completion of this study will lead to a safe, clinically feasible and accurate image guidance approach that substantially reduces the tumor positioning uncertainty, therefore reducing margin size and normal tissue toxicity.! !